Molecular and Spatial Factors Defining Tumor-specific CD8 T Cell States in Cold Tumors

PROJECT SUMMARY
Solid tumors can be classified into two broad categories, T cell inflamed (hot) and non-T cell inflamed (cold)
tumors. While hot tumors are characterized by a tumor microenvironment enriched in T cells, cold tumors of the
immune dessert phenotype, (e.g. pancreatic and breast) lack T cell infiltration. Human cold tumors exhibit
profound resistance to immune checkpoint blockade which represents a major therapeutic challenge. To design
predictably effective immunotherapies for cold tumors, we must elucidate the mechanisms that control tumor-
specific CD8 T cell (TST) dysfunctional states and therapeutic reprogramming. To fill this knowledge gap, I utilize
clinically relevant autochthonous cold tumor models, including an oncogene-driven insulinoma model. Tracking
TST differentiation longitudinally from cancer initiation to terminal endpoints, I find that TST reside in tumor
draining lymph nodes (tdLN), but fail to infiltrate the pancreas, recapitulating the cold tumor immune phenotype
of human insulinomas. TdLN TST express numerous inhibitory receptors (e.g. PD1, LAG3) and fail to produce
effector cytokines (IFNγ, TNFα). Despite their exhausted phenotype, TST express high levels of transcription
factors critical for T cell stemness and self-renewal. Strikingly, tdLN TST of do not generate differentiated
progenies, which is in sharp contrast to observations in murine and human hot tumors. This poses the intriguing
question whether the inability to differentiate in tdLN is a hallmark feature of TST in cold tumors. Interestingly,
over the course of tumorigenesis, tdLN TST lose their ability to respond to immunotherapeutic strategies. My
working hypothesis is that TST in tdLN of cold tumors fail to differentiate into effector-like TST, which is
associated with the inability to egress the tdLN and infiltrate into tumors. In this application, I will leverage the
power of autochthonous tumor mouse models as well as human samples, to identify the molecular and spatial
factors that determine TST states in cold tumors and elucidate mechanisms of resistance and responsiveness
to immunotherapeutic approaches.

Public health relevance
PROJECT NARRATIVE This project utilizes clinically relevant mouse models and patient samples to elucidate the molecular and spatial factors that determine tumor-specific CD8 T cell states associated with cold immune dessert tumor phenotypes. The proposed research will provide critical insights of mechanisms that impair CD8 T cell infiltration into cold tumors and factors associated with responsiveness to immunotherapies for the treatment of cold tumors.